Biological Sequence Quality Control and Organization

During the past year, we improved our software package VADR
(https://github.com/nawrockie/vadr) for viral sequence validation and
annotation. VADR is currently used in an automated context to process
sequences submissions of Norovirus, dengue virus, SARS-CoV-2 and and
metazoan cytochrome C oxidase subunit 1 (COX1) protein-coding gene
sequences. It is also used by GenBank sequence curators for reviewing
RSV, influenza, and mpox viral sequences. In the past year, GenBank
curators we have increased the set of models curators can use by
adding parainfluenza virus, human metapneumovirus, herpes simplex
virus, measles, mumps, and 229E, NL63, HKU1 and OC43 seasonal
coronavirus models through an ongoing collaboration with the Greninger
lab at the University of Washington.

Additionally, we have developed a new executable program in VADR,
called v-scan, which can autodetect the virus species and apply the
appropriate set of parameters for that species during
annotation. This will allow the software to be more easily applied to
other viruses in the future, and allows users to submit sequence files
with a mixture of viral sequences in them.